Malaria Vector ecology and transmission

Summary
The project goal is to investigate the urban-rural continuum of malaria transmission in relation to vector ecology
in urban, peri-urban, and surrounding rural areas of Bamako, Mali. Steps to mount effective malaria elimination
programs in African countries are confounded by the resilience of the major vector species in the Anopheles
gambiae complex. There are the well-known obstacles due to insecticide resistance and shifts in vector behavior
to outdoor residual transmission. However, the challenge of elimination is even more complex and may not be
solved even with the addition of new vector control tools. This project, which will be conducted in Mali, builds on
data from 15 years of continuous NIH ICEMR support. During this period, there has been a decline in both human
and vector transmission indicators following the scale up of core malaria control interventions. These
interventions have been primarily implemented in rural settings because of the high malaria endemicity. In
contrast, in urban settings of Bamako, there is a low prevalence of Plasmodium falciparum malaria (1-3%), and
health facilities report malaria cases diagnosed year-long with a high proportion of severe malaria. This renewal
application expends the vector ecology research capacity built in the ICEMR to address key issues related to
malaria transmission in urban Bamako and its surrounding areas. Specific Aims include: 1) Determine the
contribution of endogenous and exogenous sources of malaria mosquitoes in urban settings; 2) Determine
spatial/ temporal concentrations and survival of malaria mosquitoes in urban, semiurban, and surrounding rural
areas; 3) Assess insecticide resistance of Anopheline mosquito vectors in different ecological settings, in
association with selection pressure regimes and potential impact on malaria transmission. This approach will
generate new findings of high public health importance considering accelerating socio-economic and
environmental changes in West African cities. Research will detail how future shifts in the species composition
of primary and secondary local vector populations will change, especially with the imminent arrival of the invasive
Anopheles stephensi. Overall, this project takes a holistic approach to reveal new aspects of vector ecology that
impact the complexity and changing epidemiology of malaria parasite transmission in West Africa.